Impact of Immune Activation on Cardiovascular and Immune Health in RA

Untreated rheumatoid arthritis (RA) carries high morbidity, including musculoskeletal disability and
cardiovascular disease. Fortunately, in the past 15 years we have been able to control rheumatoid arthritis very
well by offering methotrexate alone, leflunomide alone, TNF blocker therapy, rituximab, or a combination of
methotrexate and a biologic (genetically-engineered proteins derived from human genes) therapy. At the same
time, it is known that biologic agents contribute to an increased incidence of serious infections, impaired host
response to vaccines, and a modest increase in risk for cancer. For certain, these agents block both
pathogenic autoimmune disease activity pathways as well as the beneficial host response and host defense
pathways. Furthermore, rheumatoid arthritis itself is associated with increased systemic immune activation and
risk for cardiovascular disease. Our data, and that of others, indicate that chronic immune activation likely
contributes to immune dysfunction, as measured by host response to neo-antigen and recall antigen
immunization, and that immune activation predicts cardiovascular disease in the setting of chronic infection.
We propose here to investigate determinants of immune health in the setting of auto immune disease by
testing the hypothesis that in rheumatoid arthritis chronic immune activation (elevated sCD14, sCD163,
TNFR2, TNF, autotaxin, and CD8/DC/monocyte activation) predicts immune dysfunction, as manifest by
impaired host response to vaccine, and cardiac disease. This relationship is interrupted by TNF blockade. Aim
1: Determine whether immune activation, as reflected by elevated levels of sCD14, sCD163, autotaxin,
TNFR2, IL6, CRP, dendritic cell activation and monocyte activation, predict immune health, as
measured by host response to neo-antigen and recall antigen vaccine in treated RA, and whether TNF
blocking treatment modifies this relationship. Aim 2: Determine the relation between immune
activation, endothelial function, coronary atherosclerosis in RA, and whether TNF blockade improves
both immune activation and cardiovascular surrogates.

Public health relevance
Rheumatoid Arthritis is prevalent in the veteran population. Therapy for rheumatoid arthritis has greatly improved over the past 15 years, but cardiovascular morbidity and host immune impairment are in need of improved care measures. In order to improve cardiovascular and immune health in this patient population further mechanistic investigation of host immune function and cardiovascular function is intended to develop therapeutic strategies.